Longitudinal investigation of neuroplasticity during pregnancy using multiple imaging modalities

PROJECT SUMMARY/ABSTRACT
The peripartum period is a time of dramatic neurobiological change, but these changes are not well understood
across time. The peripartum period is also marked with high rates of depression. As such, the proposed
research project aims to characterize brain changes prospectively across pregnancy to better understand the
implications of neurobiological changes on mental health. Our multidisciplinary team has the necessary
expertise (developmental neuroscience, peripartum mental health, imaging science, bioethics, and maternal–
fetal medicine) to safely conduct an advanced neuroimaging study with this understudied population. Our team
members have worked together to administer repeated magnetic resonance imaging (MRI) scans with multiple
scan modalities to examine within- and between-person alterations in brain structure and function during this
period of neurobiological change. Data from our preliminary studies scanning pregnant people longitudinally
provide the foundation for this innovative project. In 100 pregnant individuals we will use advanced multimodal
MRI (structural, diffusion, and functional MRI) to study brain changes across 9 months of pregnancy using an
accelerated longitudinal design with planned missingness so that each participant contributes only 4 scans
across their pregnancy. First, we aim to characterize changes in brain structure and function across
pregnancy, including the magnitude and pattern of change in various brain volume metrics, white matter
microstructure, and functional connectivity (Aim 1). Preliminary data suggests a .41% decrease in total brain
volume per week during pregnancy, as well as decreases in cortical volume, gray matter, and cortical
thickness. Second, we aim to investigate hormonal changes (cortisol, estradiol, progesterone, and
testosterone) underlying alterations in brain structure and function (Aim 2). Our preliminary data suggest that
increases in progesterone level partially explain reductions in gray matter volume, while surges in
progesterone and estradiol levels may be linked to increased white matter microstructure. Third, we aim to
examine the potential functional consequences of brain changes (Aim 3). To explore the potential functional
consequences of changes in brain structure and function, we will collect EEG data in response to reward and
threat, assess self-reported negative affect, and evaluate cognitive function using the NIH toolbox. Participants
will also report on peripartum depressive symptoms at each assessment wave and again at 8 weeks
postpartum. The project's innovative planned missingness design will provide unprecedented insights into the
neurobiological changes that occur across the full course of pregnancy without overburdening participants. By
filling the knowledge gap regarding brain changes during pregnancy, the findings will set the foundation for
translational work given the impact peripartum depression has on individuals and their families.

Public health relevance
PROJECT NARRATIVE Despite 85% of women giving birth in their lifetimes, we know remarkably little about how the human brain changes during pregnancy and the consequences these changes on mood and cognition. The longitudinal project will provide insights into the neurobiological changes across pregnancy using multiple magnetic resonance imaging modalities, how hormonal shifts may influence these changes, and whether brain changes are associated with mood, cognition, and mental health. The findings will contribute fundamental knowledge on the human brain with translational relevance for the individuals and families affected by peripartum depression.